Administrative Core

The Administrative Core (Core A) will provide programmatic direction, evaluation of the scientific progress and direction of the individual projects, and facilitate interaction among investigators. In addition, it will be responsible for the day to day administrative and secretarial support, and will provide financial reports and oversight of the projects and other cores. A Program Project Management Committee consisting of the Project Leaders will be responsible for planning and dealing with local issues. An Internal Advisory Committee will evaluate the Program Project on an annual basis to assess progress and direction. The Administrative Core will also be responsible for evaluation of the entire program by outside consultants and by an External Scientific Review Advisory Committee.